2024 Lysosomes and Endocytosis Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
NIH supported research aims to advance our understanding of biological systems, improve the control of
disease, and enhance health. Despite the well-recognized importance of connecting researchers working at
the forefront of fundamental cell biology with those studying the pathogenesis and eventual treatment of
disease, conferences that bridge these approaches are remarkably scant. The 2024 Gordon Research
Conference on Lysosomes and Endocytosis will be particularly impactful in this area, with a theme of
“Mechanisms, Molecules and Therapeutic Opportunities across the Endolysosomal System” and a distinctive
focus on neurodegenerative disease including Alzheimer’s Disease and Alzheimer’s Disease Related
Dementias (AD/ADRD). This conference will facilitate interaction and collaboration between cell biologists,
neuroscientists, geneticists, neurologists, and others in related biomedical fields and at different stages of their
career. By bringing together the leading experts working to understand normal and pathologic function across
the endolysosomal system, the Lysosomes and Endocytosis GRC/GRS will be a unique opportunity to
disseminate knowledge, foster interdisciplinary interactions and learning, and provide outstanding networking
and mentorship opportunities. The GRC is preceded by the Gordon Research Seminar (GRS), a unique forum
for trainees and early career scientists to present and exchange new data and cutting-edge ideas. The goals of
the Lysosomes and Endocytosis GRC/GRS are to 1) provide a comprehensive and integrated platform for
disseminating the latest discoveries related to the function and physiology of the endolysosomal system; 2)
build bridges between basic and disease-focused researchers; and 3) foster discussion of new concepts,
hypotheses, technical approaches, and research collaborations. An important aspect of this is to provide
career development opportunities for new faculty and trainees, along with opportunities for women and others
from underrepresented groups to interact with established and successful scientists. These goals will be
accomplished by a broad-based and inclusive speaking program, poster sessions at which all attendees are
encouraged to present, and intentional efforts to encourage discussion and social interaction outside of
presentations to allow for exchange of ideas and development of collaborations and future training
opportunities. This meeting is the preeminent international conference for advancing research on the
endolysosomal system and will highlight the latest in new understanding of endo-lysosomal function with a
particular emphasis on how defects across the endolysosomal system contribute to the triggering and
progression of neurodegenerative diseases and especially Alzheimer’s disease and related dementias
(AD/ADRD).

Public health relevance
Narrative Neurodegenerative diseases of all types – and especially Alzheimer’s disease and related dementias – represent an ever-increasing public health crisis as our society ages without effective therapeutic interventions. Recent advances in both biological and genetic studies implicate changes in cellular compartments known as endosomes and lysosomes in the onset and/or progression of these diseases. The goal of the Lysosomes and Endocytosis conference and seminar is to assemble a multidisciplinary group of researchers to discuss and debate the molecular mechanisms responsible for formation and function of these compartments with particular focus on their contribution to neurodegenerative disease.